The Reciprocal Relationship between Binge Drinking and Astrocytic Signaling

Excessive binge alcohol consumption causes major health and socio-economic issues within the
United States. Finding ways to reduce binge like consumption therefore remains an important
field of research to decrease the development of ethanol dependence. This project seeks to
determine if astrocytes and the neuroimmune system represent novel targets by which to curb
excessive consumption. This grant determines the influence of excessive ethanol on astrocytic
activation and function in the hippocampus as well if the proinflammatory cytokines are
responsible for glial maladaptations (Aim 1). Because sex-differences can alter neuroimmune
responses, these studies will elucidate the impact of sex on both astrocyte activation and their
function. Secondly, these studies will determine if hippocampal astrocytic signaling can be
switched to reverse the influences of ethanol on the increased proinflammatory microenvironment
and decreased glutamatergic tone of the hippocampus (Aim 2). Finally, because both glutamate
and proinflammatory cytokines can impact hippocampal dependent memory tasks and
consummatory behaviors, these experiments will determine the impact of astrocytic signaling on
ethanol consumption and alcohol-induced cognitive deficits (Aim 2). The development of
astrocyte specific DREADDs allows us to manipulate G-protein coupled receptor signaling in the
hippocampus using site directed stereotactic viral delivery. Altogether, these two aims will test our
overall hypothesis that there is a reciprocal and reinforcing relationship between alcohol and
astrocyte activation mediated by the influence of astrocytes on glutamatergic tone and
proinflammatory signaling cascades. These innovative studies will provide insight into the role of
astrocytes in the transition to alcohol dependence as well as the influence of alcohol-induced
neuroimmune dysregulation on the astrocytic response.

Public health relevance
The current treatments for alcohol use disorders are not universally effective, so determining new therapeutic areas is of critical concern. Astrocytes, key regulators of the neuroimmune response and neurotransmission, represent a novel target by which to reduce excessive alcohol consumption. The results of the current study will explore the viability of reducing binge drinking and cognitive deficits through manipulating astrocytic regulations of neuroimmune and glutamate signaling